Predicting Cognitive Outcomes from Stroke Based on Lesion Location

Abstract
Having a stroke is a frightening experience for both the patient and their loved ones. A major source of anxiety
is not knowing what stroke-related deficits will persist – will my loved one ever be able to talk again? The
likelihood for recovery is estimated by the treating neurologist or rehabilitation specialist based on their
personal experience. There are no tools available that can use information about the location of the stroke,
query it against the outcomes from hundreds or thousands of other individuals, and generate a personalized
quantitative prediction of stroke-related deficits and prognosis for long-term recovery. Here, we propose to
develop such a tool. At the University of Iowa we have one of the most comprehensive lesion registries in the
world of some 3,500 patients with focal acquired brain lesions, neuroimaging, and extensive data on outcomes.
We propose to capitalize on this unique resource by developing a tool to predict cognitive outcomes from
stroke based on lesion location. First, we propose to map brain regions most associated with specific cognitive
deficits across over 1000 patients, including symptoms such as difficulty speaking or problems with attention.
Next, in a prospectively collected cohort with acute ischemic stroke we will attempt to predict cognitive
outcomes by querying lesion location against the aforementioned symptom ‘maps.’ We hypothesize that lesion
location will be a significant predictor of chronic cognitive outcomes. Second, we have recently developed an
innovative strategy that links lesion-associated deficits to specific brain networks. It combines traditional lesion
mapping with human connectome data from healthy adults to infer what networks are disrupted by focal brain
lesions. We will evaluate whether this lesion network mapping approach can be used to compliment the
traditional lesion mapping approach to predict additional variance in cognitive outcomes. Finally, we will use
advanced statistical modeling to evaluate how predictive information from lesion location can be optimally
integrated with demographic information and baseline screening cognitive performance to maximize
predictions of chronic cognitive outcomes in a longitudinal cohort. By addressing these objectives, we will lay
the foundation for developing a clinical tool that can be applied to a clinically-acquired MRI scan to aid in
determining the prognosis of cognitive outcomes, a key factor that will help in the early management,
rehabilitation, and life planning for patients with stroke.

Public health relevance
Public Health Relevance We propose to map specific domains of cognitive impairment that occur following focal brain injury, such as deficits in language, memory and attention, to specific brain regions. We will evaluate whether these symptom- specific ‘maps’ can be used with other sources of predictive information to advance stroke management by predicting personalized cognitive outcomes.